Development of a clinically relevant mouse model of lung cancer cachexia to study pathoetiology and therapeutic strategies

PROJECT SUMMARY
Cancer cachexia (CC) is characterized by unintentional weight loss secondary to adipose and skeletal
muscle tissue wasting. It results from a complex interaction between the tumor and host, where tumor released
factors reprogram peripheral organ and tissue metabolism to cause wasting. CC affects a majority of patients
with lung, pancreatic, and gastrointestinal cancer, in addition to patients with other advanced stage cancers,
and is associated with increased treatment-related toxicity, poor response to chemo- and immunotherapy and
is estimated to cause ~20% of all cancer-related deaths. Lung cancer is the second most common cancer
worldwide and the leading cause of cancer-related deaths. A majority of lung cancer patients exhibit signs of
CC at diagnosis, with up to 75% experiencing tissue wasting during treatment. Oncogenic KRAS mutations
increase the risk for CC and are found in many aggressive cancers that are prone to CC, including pancreatic,
gastrointestinal and lung cancer. In fact, a large majority of lung adenocarcinomas show evidence for elevated
Ras pathway activation (84%). Studies have described murine lung cancer models with mutated Kras that
develop CC, but these models fail to reproduce the pathophysiology and time course of CC in human patients.
Thus, our goal is to develop and test mouse Kras driven lung cancer models that more accurately reproduce
the clinical condition to facilitate identification of pathoetiological mechanisms and to provide an experimental
system that enables testing of pharmacological and supportive care interventions over a more clinically
relevant time frame. This proposal builds on our strong preliminary results from lung club cell specific KrasG12D
mouse models characterizing the phenotypes and time course of CC initiation and progression. Based on our
preliminary data, we hypothesize that our KrasG12D lung adenocarcinoma model more closely mimics the
pathophysiology of human CC in its phenotypes and time course compared to a similar Kras driven mouse
model that aligns with the rapid time course of commonly used murine lung CC models. To develop this model
and test our hypotheses, we will use a combination of genetically engineered mouse models and in vitro
models consisting of tumor organoids developed from these animals, along with skeletal muscle and adipose
cell cultures. Results from our studies will advance the field by providing novel in vivo and in vitro models to
study the pathophysiology of CC and to test therapeutic interventions. Collectively, these tools and knowledge
will inform translation of basic science discoveries into more effective treatments for CC in patients.

Public health relevance
PROJECT NARRATIVE Cancer cachexia is a syndrome characterized by weight loss secondary to skeletal muscle and adipose tissue wasting that occurs in certain cancer types, such as lung, pancreatic and gastrointestinal, and advanced stages of other cancer types. Despite the prevalence and grave consequences of this syndrome, the mechanisms underlying cancer cachexia remain unknown and there are currently no available treatments. The proposed studies are designed to address the critical barrier of translating the data from animal models into human cancer patients by developing and testing novel murine models of cancer cachexia and in vitro models to further define the pathoetiology of cancer cachexia, identify therapeutic targets, and provide an experimental platform for testing pharmacotherapeutic and supportive care interventions.